PROTEIN RESTRICTION &KETOACID SUPPLEMENTATION EFFECT ON GLUCOCORTICOIDS

Does the addition of phosphorus to the diet daily increase 17- hydroxycorticosteroids, free cortisol excretion and urea nitrogen excretion?